Testing in-situ formed nanofibers for inhibiting metastatic osteosarcoma (mOS) in murine models

Abstract
The treatment outcome of metastatic osteosarcoma (mOS) remains poor and has not improved for over
four decades. Thus, developing novel approaches for treating mOS is urgently needed. We unexpectedly find that
enzyme-instructed self-assembly (EISA) is able to form nanofibers (NFs) inside the nuclei of mOS cells and
selectively killing the mOS cells in cell culture. This proposed pilot study is to test the in-situ formed NFs for
inhibiting tumor growth in murine models. This research program will focus on two specific aims: Aim 1,
synthesis and characterization of the molecules for EISA in the nuclei of mOS cells; Aim 2, pilot study of the
EISA substrates for inhibiting mOS tumors in clinically relevant murine models. The rigor of prior research is that
(i) overexpression of alkaline phosphatase (ALP) is a key feature of mOS, (ii) our preliminary results show
that EISA forms NFs inside nuclei to selectively inhibit mOS cells, and (iii) EISA forms cytosolic NFs to
selectively inhibit mOS tumors in vivo. The innovation is to target the nuclei of mOS cells by EISA. The
success of the proposed studies will contribute to the development of new molecular targeting agents for
selectively killing mOS, which may ultimately lead to breakthrough in treating mOS.

Public health relevance
Narrative The proposed study will test innovative molecular targeting agents for developing treatment of metastatic osteosarcoma (mOS), a lethal disease. This project will contribute to developing treatments that improve outcomes for patients with lethal bone tumors.